The Role of Proteases and Peptides in Cancer Pain

DESCRIPTION (provided by applicant): Cancer pain has a major impact on quality of life and clinical treatment of patients. Oral cancer patients rate pain as their worst symptom. Effective treatment of cancer pain remains a critical, unmet goal in cancer research. The proposed study will provide a molecular rationale for the development of mechanism-based therapeutic treatments to reduce oral cancer pain, and cancer pain in general, and allow patients to regain their function. Cancer cells and cancer-associated stromal cells secrete a complex ensemble of bioactive factors into their surroundings to promote cancer growth. A subset of these molecules also sensitizes nociceptors on nearby primary afferent sensory neurons, creating crosstalk among nociception and cancer growth pathways. The proposed research is a targeted sampling and proteomic approach to characterize pain-producing proteases and peptides within the cancer microenvironment. The experimental advantage of our intraoperative microdialysis collection technique is the direct sampling of cancer-associated proteins and peptides in vivo. The nociceptive effect of molecules will be evaluated and confirmed using a well- established cancer pain mouse model. Secreted proteases are promising, yet largely unexploited drug targets for manipulating the levels of pain-producing peptides. We hypothesize that selective inhibition of specific proteases will decrease levels of nociceptive peptides in the cancer environment and relieve cancer-associated pain. The data generated from the proposed studies will provide the molecular basis for an entirely new perspective with which to understand and treat cancer pain.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Public Health relevance of this project is that successful completion will provide the foundation for a clinical trial based on the pain-producing molecules that we discover. Ultimately, this work could lead to improved treatment for cancer pain. PUBLIC HEALTH RELEVANCE STATEMENT The Public Health relevance of this project is that successful completion will provide the foundation for a clinical trial based on the pain-producing molecules that we discover. Ultimately, this work could lead to improved treatment for cancer pain. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Cancer cells and cancer-associated stromal cells secrete a complex ensemble of bioactive factors into their surroundings to promote cancer growth. Secreted proteases are promising, yet largely unexploited drug targets for manipulating the levels of pain-producing peptides such as endothelin-1, which has been shown to influence cancer growth via autocrine and paracrine signaling pathways. Other members of the peptide growth factor repertoire also sensitize nociceptors on nearby primary afferent sensory neurons and create crosstalk among nociception and cancer growth pathways. Analgesic treatment may affect cancer progres- sion due to the same complex signaling overlap. Thus, a mechanism-based understanding of cancer- associated pain will have tremendous impact on the development of pain-reducing therapeutic treatments. The proposed research is a targeted sampling and proteomic approach to expand our current expertise in characterizing and manipulating pain-producing peptides within the cancer microenvironment. Our prelimi- nary studies have demonstrated that our microdialysis technique of collecting extracellular proteins in the interstitial fluid surrounding tumors reveals pain-producing proteases and peptides. The experimental ad- vantage of our intraoperative microdialysis collection technique is the direct sampling of cancer-associated proteins and peptides in vivo. Following collection we apply our mass spectrometry-based approach PA- LeO (protease activity labeling employing 18O) to detect and characterize proteolytic reactions that occur in the microdialysate samples ex vivo by monitoring the enzyme-catalyzed incorporation of stable isotopes. Using these methods, we have identified cancer-secreted proteases (e.g., numerous matrix metalloprote- ases) and endogenous peptides (e.g., hemorphins, endothelin-1) within the cancer microenvironment of pa- tients. We have quantified endothelin-1 concentrations across patients, and confirmed its presence and its nociceptive effects in the cancer pain mouse model that we developed. Further, we characterized the metabolic regulation of endothelin-1 by the endothelin-converting enzyme 1. Based on these findings, we postulate that we can identify additional algogenic peptides and determine which proteases are responsible for their activation and deactivation. To address these key issues in cancer pain, we will focus on identifying nociceptive peptides in the micro- environment of oral squamous carcinomas, characterize their origin and determine their role in mediating pain. By associating individual peptide species to proteases that activate or deactivate them, we will eluci- date the molecular mechanisms that regulate peptide signaling. Based on our preliminary studies, we plan to expand our efforts of identifying pain-mediating peptides and their metabolizing proteases in the microen- vironment of oral cancers. We hypothesize that selective inhibition of specific proteases will decrease levels of nociceptive peptides in the cancer environment and relieve cancer-associated pain. We will address the following Specific Aims: Specific Aim 1. Define the repertoire of peptides and proteases that produces pain in the cancer microenvironment of oral cancer patients. We will use intraoperative microdialysis and functional MS- approaches to systematically characterize algogenic peptides and proteases in the microenvironment of human oral squamous cell carcinomas. We will rank the collected and identified molecules based on their correlation with patients' reported pain using a validated cancer pain questionnaire. The nociceptive effect of the molecules will be evaluated and confirmed using a well-established cancer pain mouse model. Specific Aim 2. Define and manipulate protease-mediated peptide nociceptive pathways in oral squamous carcinomas co-culture systems. We will identify, characterize and antagonize protease- mediated peptide nociceptive pathways in oral squamous carcinomas cell lines, normal oral keratinocytes and co-culture systems with trigeminal neurons and fibroblasts. We will rank the protease-peptide path- ways identified in this aim based on their association with cancer and their overlap with the molecules iden- tified in Specific Aim 1. We will determine their nociceptive capacity in the mouse cancer pain model. In parallel, we will apply our MS-platform to match elusive substrates to their metabolizing proteases. We will use our MS-platform, the cell culture model and the mouse model to assess the effectiveness of targeted protease inhibition on the production of nociceptive peptides and pain in general. The data generated from the proposed studies will provide the molecular basis for an entirely new perspec- tive with which to understand how cancer pain is associated with cancer biology. Furthermore, these ob- servations are critically needed for rational, targeted manipulation of pain-mediating proteases. Such a mechanism-driven strategy to improve our understanding and treatment of cancer pain will be fundamental to efforts aimed at improving cancer patient quality of life and survival.